Targeted disruption of the YAP/TAZ/TEAD axis in pancreatic cancer

Project Summary/Abstract
Pancreatic ductal adenocarcinoma (PDAC) is a devastating form of pancreatic cancer with dismal patient
outcome. KRAS, which is commonly mutated in PDAC, is a driving oncogene in this disease. However,
development of approaches to target KRAS has proven challenging and inhibitors targeting signaling networks
downstream of KRAS such as the MAPK pathway have largely failed as single agents. The overall goal of this
proposal is to use innovative chemical strategies to identify combination regimens in PDAC, which are urgently
needed to improve patient survival. Combining CRISPR screens and epigenomic profiling, I identified that the
YAP/TAZ/TEAD axis is a critical transcriptional node required for the bypass survival program upon KRAS loss
or MEK inhibition. This data and published literature support the importance of directly targeting the
YAP/TAZ/TEAD axis in PDAC. However, current YAP/TAZ/TEAD inhibitors have poor potency and off-target
effects and genetic strategies to study critical transcription regulators have limited utility due to delays between
protein loss and experimental measurement. To overcome these limitations, I developed a versatile tag-based
technology platform known as the degradation tag (dTAG) system to induce rapid degradation of any target
protein in cell lines and mouse models. The dTAG system enables evaluation of target protein loss with a small
molecule degrader in a time-scale that is not possible with genetic approaches, facilitating evaluations of mutant
KRAS, YAP and TAZ. In addition, the Gray laboratory developed a selective small molecule covalent TEAD
inhibitor to irreversibly inactivate aberrant YAP/TAZ/TEAD signaling. The work proposed in this application will
leverage the dTAG technology platform and a covalent TEAD inhibitor to establish the role of YAP/TAZ/TEAD in
coordinating bypass survival in PDAC. In Aim 1, in the absence of direct YAP or TAZ inhibitors, I will use the
dTAG system to define the direct YAP and TAZ transcriptional signaling program that promotes survival upon
modulation of KRAS signaling. These experiments will demonstrate the potential of chemical degradation of YAP
and TAZ and identify novel targetable vulnerabilities. In Aim 2, I will use PDAC cell lines and patient-derived
organoid models to evaluate the translational potential of covalent TEAD inhibition as a combination regimen
with KRAS signaling disruption. Integrating chemical biology, genome-scale analyses, and translational models
of PDAC, I expect that PDAC-specific therapeutic insights will emanate from this work. To achieve these aims, I
designed a 3-year plan that includes participation in scientific and career development meetings, workshops and
coursework to further develop my cancer chemical biology and computational biology expertise. This career
transition award will greatly facilitate my goal of leading a multidisciplinary research laboratory focused on
addressing challenges in the treatment of pancreatic cancer.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is an aggressive form of pancreatic cancer with limited therapeutic options. The goal of this proposal is to identify combination treatment strategies that enhance existing PDAC therapies by chemically degrading or inhibiting key gene-regulatory proteins. This work will guide the deployment and development of targeted therapeutics aimed at proteins responsible for drug resistance mechanisms in PDAC.